Epithelial Cell and Mucosal Immunology

The Epithelial Cell and Mucosal Immunology Core (Core C) provides the infrastructure, biologic resources, expertise, and training for innovative and cross-disciplinary research on epithelial biology and immune function in mucosal surfaces and solid organs of the GI tract. Specific activities and services include: · Polarized Epithelial Cell Culture and Genetic Transformations · nCounter NanoString RNA Analysis · FACs 7- or 12-Color Analysis Of Cultured Cells or Tissue/Organoid-derived Primary Cells · Transepithelial Electrophysiology of live cells, cell monolayers, and tissues · Gastrointestinal Organoid Derivation and Culture · Specialized Equipment, Reagents, Training, and Consultation for recombinant protein expression and purification, including small molecules, specialized and unique epithelial cell lines, expression profiling using Bio-Plex MAGPIX multiplex reader · Research and Development of live cell ratio fluorescence imaging of ion and solute transients, and FRAP analysis of membrane molecules A total of 27 HDDC members and 20 non-Members used Core C in the last grant cycle as measured in billable hours of service. 8 HDDC Members used Core C services in every quarter. The Core recorded >4000 billable hours/year. 45 Members and Associate Members anticipate use of Core C in the next grant cycle. All services will be utilized.